2022 Quantitative Genetics and Genomics Gordon Research Conference and Seminar

Project Summary
The application seeks partial support for the Gordon Research Conference and Gordon Research Seminar on
Quantitative Genetics and Genomics to be held in Ventura, California on February 11-17, 2023. The subtitle of
the conference is “Leveraging high-throughput phenotyping techniques to study complex traits”. Complex
diseases (e.g. cardiovascular disease) and complex or quantitative traits (e.g. obesity) are of great importance
to human health. Over the last decade there has been a revolution in research on these diseases due to
availability of DNA variant genotyping, genome sequencing and other “omics” technologies. This revolution is
continuing with the availability of enormous datasets such as the UK biobank and USA equivalent with
1,000,000 people all with health records and imputed genome sequence. Extracting maximum knowledge from
such data is challenging and this conference will hear of the latest research on this topic. The outcomes from
this research include new drug targets and information to support personalised medicine.
The overall aim of the conference and seminar is to bring together scientists working in the field of quantitative
genetics and genomics to exchange information on the latest results in the field and to discuss the implications
of these results. By creating an environment for networking, this conference will promote communication
between scientists in the field, encourage new collaborations among those attending, and build a community
for early career scientists. The funding sought from NIH is to support young scientists to attend the seminar
and conference by assisting them with travel and registration costs.

Public health relevance
Project Narrative The Gordon Research Conference and Seminar on Quantitative Genetics and Genomics will hear of the latest advances in knowledge on the genetics of complex traits, such as high blood pressure, and complex diseases, such as diabetes. This research will lead to new treatments and to personalised medicine so that each patient can have the most suitable treatment for them personally.